PUI RESEARCH-ALCORN-MCGEE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The primary focus of this subproject will be to assist the outreach director. The main emphasis will involve recruiting students for the REO program, and visiting labs that have the ability to serve as REO host labs. We also plan to build and maintain a data of student activities and input.